PET imaging of microtubules in cognitively normal and impaired older adults

Project Summary/Abstract
Microtubule (MT) integrity is critical for cell function and viability. Its disruption in Alzheimer’s disease
(AD) is commonly attributed to hyperphosphorylation of the MT-associated protein, tau. However, the time
course of MT instability in neurodegenerative cascade of the disease progression remains unknown. In vivo MT
imaging offers an opportunity to gain this critical information on MT changes in relation to staging of AD. As MT
destabilization is a common factor in both Aβ and tau-based AD pathologies, we hypothesize that a targeted MT
PET radiotracer can be used as an early indicator of neuronal health and brain functions prior to onset of AD
symptoms. Our lab reported the first brain-penetrant MT PET ligand, [11C]MPC-6827, and evaluated its imaging
potential in vivo in rodent and non-human primate (NHP) models of AD. We evaluated its safety and radiation
dosimetry profile in six healthy male and female volunteers and its imaging efficacy in two cognitively normal and
two impaired older adults. Our mechanistic studies showed that [11C]MPC-6827 is selective for destabilized
tubulins, and uptake increases with Aβ/tau burden in AD brain. The proposed trial will the first to measure the
efficacy of an MT-based PET ligand as an early imaging biomarker in cognitively normal and mildly cognitively
impaired/early AD subjects.
We propose to conduct a clinical PET imaging study of [11C]MPC-6827. In Aim 1, we will determine
the metabolic, pharmacokinetic, and imaging distribution parameters of [11C]MPC-6827 in three groups (n=75,
25/group) of participants, to be enrolled from the Wake Forest AD Research Center: 1) cognitively normal
adults who are amyloid PET negative; 2) cognitively normal adults who are amyloid PET positive; and 3) adults
with MCI or early AD who are amyloid PET positive. All the groups will be matched for age and sex. In Aim 2,
[11C]MPC-6827 imaging parameters will be compared among the three groups and correlated with individual
amyloid and tau PET measures, cerebrospinal fluid (CSF) measures, age, and cognitive scores. In Aim 3, we
will perform longitudinal PET/CT scans with [11C]MPC-6827 in all the subjects (n=25/group) from Aim 1, 24
months after their first scan. Relationship of MT destabilization and disease progression will be established by
correlating the radiotracer uptake with their associated amyloid and tau burdens. All the imaging analyses will
be performed blinded to subject diagnosis. This study will provide rich imaging data source to validate MT
destabilizations as an early neurodegenerative biomarker for AD pathogenesis.

Public health relevance
Narrative As amyloid beta and tau pathology accumulate in the brains of people with Alzheimer’s disease (AD), microtubule (MT) stability is heavily compromised. We propose a clinical imaging study of a novel MT-based PET radioligand, [11C]MPC-6827 in cognitively normal and mildly impaired/early AD older adults to determine its utility in imaging early stages of AD.